This service is for the External Oversight Committee (EOC) of the Blueprint Neurotherapeutics Network for Biologics (BPN-Biologics) is an external advisory group of experts directed to provide indepen

The purpose of this requirement is to procure biological therapeutics consulting services in support of NIH Blueprint Neurotherapeutics Network for Biologics (BPN-Biologics) drug discovery and development programs and the associated BPN-Biologics External Oversight Committee. The NIH is seeking to procure a highly experienced executive-level, drug discovery and development subject matter expert with experience in the area of biological therapeutics to provide feedback to the NIH program leadership and technical guidance on drug discovery and development projects within the BPN-Biologics portfolio. The Contractor will serve as a member of the BPN-Biologics External Oversight Committee, which provides strategic guidance on BPN-Biologics projects and on occasion other NIH drug discovery and development programs.